Discovery and Development of a Benzoquinone Molecule as a Novel Anesthetic

Although the field has made substantial progress in understanding how anesthetics induce unconsciousness,
amnesia, and immobilization, the exact mechanisms remain poorly understood. Furthermore, all sedative-
hypnotic agents cause undesirable adverse effects. Thus, there is a need to discover new sedative-hypnotics
and to advance our knowledge of their mechanism(s) of action. We previously found that the anesthetic,
propofol, interfered with electron transfer within mitochondria at the level of coenzyme Q (CoQ) and induced
excessive proton leak. These “two-hits” combined to compromise the mitochondrial membrane potential (ΔΨm)
by degrading the proton motive force and preventing the requisite ramp up in electron flux to regenerate it. In
preliminary work, we observed that synthetic CoQ analogs (members of the 1,4-benzoquinone class) cause a
similar increase in mitochondrial leak and precipitate a decline in ΔΨm. Extending these observations, we
found that tail vein injection of the short-chain CoQ analog, ubiquinone-5 (Ub5), immediately induced
unconsciousness in mice. These provocative findings led us to our global hypothesis: 1,4-benzoquinones
represent a novel class of sedative-hypnotics. We specifically hypothesize that Ub5 induces unconsciousness
by compromising ΔΨm. Thus, the aims are designed to: 1) characterize the anesthetic effects of Ub5 and 2)
determine how Ub5 prevents forebrain mitochondria from generating an adequate ΔΨm. The third aim is
designed to identify the neuronal aspartate-glutamate mitochondrial carrier, Aralar, as a novel
pharmacologically relevant anesthetic target. The basis for this aim is our preliminary data demonstrating that
Aralar is a major source of Ub5-mediated proton leak. In specific aim #3 we will determine the role of Aralar in
mediating Ub5-induced unconsciousness. Success of the proposal will establish Ub5 as a novel anesthetic
agent and elucidate discrete mitochondrial mechanisms of action. Knowledge gained will permit us to discover
sedative-hypnotics with precise mitochondrial targets in future work; maximizing on-target therapeutic
biological activity and minimizing off-target toxic effects.

Public health relevance
The mechanisms by which anesthetics induce unconsciousness, amnesia, and immobilization are poorly understood. We aim to characterize the anesthetic effects of a novel intravenous sedative-hypnotic agent, determine how it prevents forebrain mitochondria from generating an adequate mitochondrial membrane potential, and identify a new pharmacologically relevant anesthetic target. Success will provide insight into mechanisms of anesthesia and will permit us to develop the safest and most effective sedative-hypnotics in future work.